Microscopy & Digital Imaging Core

ABSTRACT
Microscopy, Digital Imaging and Histology Module
Advances in imaging combined with enhanced capabilities to label cells and tissues have greatly
improved the ability to utilize animal and cell culture models to study cellular processes and
disease pathogenesis. The Microscopy, Digital Imaging and Histology module of the Baylor
College of Medicine Vision Core provides cutting edge instruments for advanced, high-resolution
imaging of cells, tissues and live animals and expert support for processing, sectioning and
staining samples, as well as image acquisition and analysis. The imaging technologies
offered by the module includes electron microscopy, light and epifluorescent microscopy and
multichannel and multiphoton confocal microscopy. The advanced imaging capability available to
vision core investigators at BCM will enhance their ability to thoroughly investigate disease models
and to evaluate efficacy of novel therapy approaches. The module will also enhance collaboration
between vision researchers at BCM because of the close proximity of core facilities to
investigator's labs and shared imaging expertise between investigators and staff.

Public health relevance
NARRATIVE Microscopy, Digital Imaging and Histology Module High-resolution digital imaging of cells and tissues is essential for the translational disease modeling performed by the Vision Core investigators. ThisMicroscopy, Digital Imaging and Histology module provides the latest imaging technology and expert support to investigators for their studies of visual system morphology, disease pathogenesis and therapeutic efficacy.